Ferroptosis in drug resistant glioma

Project Abstract
Cancer drug resistance is the last frontier in extending patient overall survival, especially in the deadly
brain tumor – glioblastoma (GBM). GBM currently has one standard of care chemotherapeutic agent –
temozolomide (TMZ) – which extends median overall survival to ~14-16 months. However, TMZ resistance is
rapid and uniformly fatal. Yet, because there are some long-term responders (~5% at 5 years), almost all newly
diagnosed GBMs will receive TMZ, making TMZ-resistance a major clinical unmet need, and the focus of my
previous, current, and future work. The central goal of my current work is to better understand the distinct
changes in the metabolic states between TMZ-Sensitive (TMZ-S) and -Resistant (TMZ-R) disease, allowing for
the discovery of therapeutically targetable vulnerabilities. To this end, I have found that TMZ-R cells have a
greater dependence on cystine import, increase of intracellular iron, and a maintained oxidative state that primes
these TMZ-R models for cyst(e)ine depletion-induced ferroptosis with a known neuroprotective agent – ebselen.
I further show that this form of ferroptosis – or iron-dependent cell death – could be induced by the selenium in
ebselen or TMZ-Selenium but not a TMZ-Sulfur analog in TMZ-R cells, which will no longer have a response to
TMZ alone. Therefore, the objective of this project is to meticulously characterize this cyst(e)ine depletion-
induced ferroptosis phenotype in TMZ-R models where it will both help in our understanding of TMZ-R GBM and
develop a framework where small molecule selenium-containing compounds could be of use in other diseases.
To accomplish this goal, I will take full advantage of my excellent mentoring/advisory committee as well as the
exceptional resources and training environment available to me at Northwestern University. The expected
outcomes of this project include a thorough understanding of the metabolic landscape and changes between
both TMZ-S and -R models, as well as shifts post cyst(e)ine depletion-induced ferroptosis (Aim 1). A
characterization and validation of the protein players that are necessary to mediate cyst(e)ine depletion-induced
ferroptosis in TMZ-R models, as well as how the increased oxidative state in TMZ-R may affect enzymatic active
site status that would not be discovered via sequencing methods but is essential for protein activity (Aim 2).
Finally, the mechanistic knowledge gained from a meticulous understanding of both the metabolic readouts and
proteomic players will allow for a smarter animal model design to answer and/or confirm the findings in Aim 1 &
2 (Aim 3). As I already have a strong background in RNA biology/splicing and DNA damage/structure in TMZ-R
disease, this proposal will strengthen my knowledge in the metabolic differences and learn proteomic and
metabolic techniques. In this way, I will have a well-rounded understanding of TMZ-R disease which will help me
to design smarter and more complete studies in the future when I run my own independent lab.

Public health relevance
Project Narrative This proposal will benefit both basic scientists in their understanding of the drug resistant brain cancer – glioblastoma – as well as chemical biologists in deriving new selenium-containing small molecules. This proposal is also directly related to the NCI’s mission statement to “help all people live longer, healthier lives” as the project uses a neuroprotective agent to treat drug resistant glioblastoma which should both extend lifespan while also decreasing toxic side effects. In this way, I believe this project will both increase our knowledge and ability to target drug resistant brain tumors in a smarter way.